Evaluating Digital Micro-Interventions to Reduce Distress and Increase Wellbeing in Breast Cancer Survivors

Project Summary/Abstract
Nearly half of all breast cancer survivors will experience clinically significant symptoms of depression and/or
anxiety in the first five years after their cancer diagnosis. However, the impact of mental health needs extends
beyond those with clinically significant symptoms. Interventions, therefore, should target the broad range of
affective, cognitive, and behavioral mechanisms that are critical to the development and maintenance of
depression, anxiety, and general psychological well-being. Our research team is currently testing a modular,
app-delivered intervention, IntelliCare, for reducing symptoms of depression/anxiety in breast cancer survivors.
IntelliCare is composed of five digital micro-interventions (DMIs)—brief, targeted, and technology-enabled
interventions that can be seamlessly integrated into an individual's daily life. In exit interviews with survivors
that used IntelliCare (n=210), there was a clear desire for the addition of DMIs that promote well-being (e.g.,
increasing social interaction, positive emotions). Pursuing DMIs that not only reduce symptoms but also
promote general well-being will allow us to reach a broader population of end-users and potentially enhance
future outcomes. In addition, although survivors generally reported that the program was easy to use, intuitive,
and accessible, many reported that built-in guidance specifically related to timing of use of the DMIs might
improve their overall impact. The constructive feedback from our current R01 trial leads us to the next logical
step of expanding the number and scope of empirically-informed DMIs for breast cancer survivors that can
ultimately be used in a future proposal that adapts the delivery of DMIs in real-time to match individual
survivors’ needs. Following the Obesity-Related Behavioral Intervention Trials (ORBIT) for developing
empirically-supported behavioral interventions, the goals of this project are: (1) to design new DMIs for breast
cancer survivors, and (2) to evaluate the feasibility of DMIs in a pre-post field trial. First, we will adopt a user-
centered design approach to identify the preferences, needs, and perceived obstacles to using DMIs among
women diagnosed with breast cancer within the last 5 years (N=20). We will initially develop up to 10 DMIs
based on feedback from our R01 trial participants and evidence-based psychological therapy components (Aim
1). Iterative feedback will be collected from survivors who will engage with prototypes of DMIs in a controlled
setting. This formative data will help us identify the most promising DMIs to be developed and evaluated in a
single-arm, 8-week pre-post study among 40 breast cancer survivors (Aim 2). The primary goal of this aim is to
evaluate the feasibility of including DMIs for a future proposal. A DMI will be considered feasible if it meets
minimum engagement metrics defined in prior studies. We will also conduct exit interviews with survivors to
inform future tailoring and personalization of the DMIs. A secondary goal is to obtain preliminary estimates of
the proximal and longer term impact of the DMIs on psychological mechanistic variables for a future proposal
to construct a just-in-time adaptive intervention that personalizes the delivery of DMIs to individual survivors.

Public health relevance
Project Narrative Mental health needs, manifested through a desire to alleviate symptoms of depression/anxiety or promote general psychological well-being, are very common among breast cancer survivors, and it is critical that easily accessible, helpful, and engaging interventions are made available. IntelliCare, an app-delivered intervention composed of five brief micro-interventions, is designed to reduce symptoms of depression and anxiety, although additional micro-interventions that promote general well-being could increase its reach to a broader population of breast cancer survivors. By means of a user-centered design process and a feasibility trial, this proposal will expand the number and scope of empirically-informed digital micro-interventions for breast cancer survivors that may result in an adaptive intervention design for breast cancer survivors that is flexible, low cost, easily accessible, and highly efficient.